Trusted Training: Improving Health and Safety Through an All-Hazard Training Approach

Program Summary/Abstract (HWWTP)
The Tony Mazzocchi Center (TMC) seeks continued HWWTP funding to support our extensive Trust in Training partnership representing over two million at-risk hazardous materials workers, chemical responders, and skilled support personnel.
Through the HWWTP five-year program, we will conduct 2,025 courses to reach 35,460 workers, managers, community residents and Tribal members with 400,340 hours of training to help prevent toxic releases, fires, explosions, injuries, sickness and death.
Target Populations: The TMC partnership has an exceptionally large, at-risk population spanning across the United States, including Puerto Rico, Guam, and the Virgin Islands. Together our partnership reaches workers in varied sectors who are exposed to hazardous substances/materials covered by OSHA Standard 29 CFR 1910, EPA 40 CFR 311, and DOT 49 CFR 171-177.